The role of an aberrant synaptome in microglia-associated synaptic pruning in C9orf72-FTD

ABSTRACT
Synapses are important structures connecting neurons and enabling fast signal transmission, providing the
building block of brain function. Advancements in sophisticated microscopy and electrophysiology technologies
have revealed significant heterogeneity among synapses, with the caveat that most of these studies have been
done in rodent model systems, while little is known about human synapse heterogeneity and molecular
composition. Synaptic dysfunction, often referred to as synaptopathy, encompasses numerous cellular,
molecular and structural changes, which ultimately lead to progressive loss of synapses, a disease-associate
phenotype originally proposed for Alzheimer’s disease, but since then also proposed as an early sign of disease
manifestation in other neurodegenerative diseases, including FTD and ALS. The latter has been demonstrated
in mouse models of familial FTD, but also in postmortem tissue of ALS/FTD patients, including those carrying
the C9orf72 mutation. More recent studies suggest that synapse loss might be preceded by changes in the
protein and RNA content of the synaptic structure itself, both pre-and postsynaptic. Meanwhile, C9orf72 protein
has been shown to be localized to the postsynaptic and presynaptic compartment, supporting C9orf72’s function
in vesicle trafficking and its activity as a Rab GTPase guanine exchange factor (GEF). Limited studies suggest
that the C9orf7 mutation induces disease-associated changes of the synaptome, but a comprehensive and
unbiased profiling of protein and RNA signatures at the diseased human cortical neuronal synapse is still missing.
At the same time, an aberrant synapse proteome and/or transcriptome have yet to be correlated with aberrant
microglia function, including synaptic pruning, and it is still poorly understood whether these pathological events
are initiated by microglia or by synaptic changes. The graduate student assigned to this project, Ashton Spillman,
will perform a comprehensive assessment on if and how signals from cortical neuronal synapses to microglia
lead to pathological synapse elimination in C9orf72-FTD using postmortem patient autopsy tissue and iPSC
neuron and microglia culture models in association with multi-omics and functional analyses. We hypothesize
that the C9orf72 repeat expansion-induced aberrant synaptome contributes to the activation of microglia and
aberrant microglia-associated synaptic pruning in C9orf72 FTD. These studies are critically important for our
understanding of what role synapse elimination plays and how it could lead to novel therapeutic target
identification, either directed at the synaptic proteome itself and/or the associated immune signaling.

Public health relevance
PROJECT NARRATIVE Synaptic dysfunction is considered an early event during disease manifestation and progression in many dementias, including frontotemporal dementia (FTD) and has been proposed to be associated with microglia dysfunction, including microglia-mediated synaptic pruning. The question remains to whether it is the aberrant proteome of the synapse or the disease-associated microglia dysfunction that triggers early synapse loss. Here we aim to define a disease-associated synaptome via multi- omics analyses of human C9orf72 FTD brain tissue derived cortical synapses and to assess whether an aberrant synaptome triggers aberrant microglia phagocytosis using human C9orf72 FTD patient- derived iPSC neuron-glia cell culture models.